Integrated Neural Engineering and Rehabilitation Training Program

This proposal describes our “Integrated Neural Engineering and Rehabilitation Training” program that
produces biomedical engineering Ph.D. graduates who combine state-of-the-art expertise in neural engineering
(an area of bioengineering) with a genuine appreciation of the practice and challenges of clinical rehabilitation.
This T32 is centered in the Department of Biomedical Engineering at Case Western Reserve University, but also
includes the strong participation of several of our local medical centers. Our T32 is focused exclusively on
predoctoral training - having trained 76 students since 1999. We are requesting funding for 2 supplemental
predoctoral positions for one year, with institutional funds to support their second year in the training program.
We expect to train a total 8 BME Ph.D. students per year with this added supplement to our program. Trainees
enter with undergraduate training in engineering or a closely related discipline. They satisfy the rigorous
requirements of the BME Ph.D. program and benefit from its existing features, while our T32 program adds value
through highly collaborative and interdisciplinary research projects, a clinical immersion experience, and unique
access to visiting seminar speakers. We are creating a virtual reality-based Neural Anatomy course (exploiting
our unique relationship with the Microsoft HoloLens program), including formal and informal diversity training,
and diversifying out mentoring pool with more faculty with industry experience, underrepresented trainers, to
facilitate the recruitment and training of women, minorities, and disadvantaged students to the program.
The specific objectives of our training program are: (1) Prepare our trainees for productive careers in
rehabilitation and neural engineering; (2) Provide a rigorous engineering education that forms the basis for future
innovation; (3) Provide specific expertise in the development and application of neural stimulation and
interventions for overcoming neurological disorders; (4) Provide specific expertise in modeling and simulation;
(5) Provide an extensive, hands-on clinical immersion experience that prepares each trainee for a translational
career; (6) Provide specific expertise in the deployment and integration of Brain Computer Interfaces; and (7)
Provide real-world professional development training to enhance post-graduation success.
We have assembled a distinguished group of mentors who serve in one of three roles: Research Training
mentors (17) who are the primary research advisors of the trainees, Associate Research Training Mentors (5)
who are content experts on T32 trainee committees, and Clinical Training Mentors (12) from rehabilitation and
surgical disciplines who insure the clinical relevance of each trainee research project. We are in the process of
adding new mentors (3) to further diversity the mentor pool. Trainee project topics include electrode
development; brain computer interfacing; sensory restoration; pain management; stimulation pattern design;
neural motor control mechanisms; neural biomaterials, protection, and repair; interventions to individuals with
neurological disorders; neurorehabilitation; modeling and simulation; and brain-computer interfacing.

Public health relevance
Relevance to Public Health. The number of people in the U.S. living with movement-related disabilities is staggering. Disability due to neurological disorders can often be mitigated by the careful application of electrical stimulation to specific neural structures. Both research and commercial applications related to neural stimulation are growing very rapidly, leading to a real need for highly qualified, Ph.D.-level engineers who have the technical and clinical backgrounds provided by this program.